Planning and Evaluation Core

PLANNING AND EVALUATION CORE – ABSTRACT
Our Chicago Cancer Health Equity Collaborative (ChicagoCHEC) Planning and Evaluation Core (PEC) is
comprised of an exceptional team with complementary expertise and responsibility to lead the core’s monitoring
and evaluation activities. PEC members include: Drs. Kristi Holmes and Brian Hitsman from NU-LCC; Raymond
Fuller and Dr. Wamucii Njogu from NEIU; and Drs. Timothy Johnson and Lisa Sanchez-Johnsen from UIC. This
Renewal application for the ChicagoCHEC PEC proposes to build on the infrastructure created, program
progress, and lessons learned from our first U54 award and continue to improve our integrated and responsive
foundation to support planning, monitoring and evaluation. The PEC will continue to monitor progress through
ongoing evaluation processes, maximize resources, identify novel directions for the Partnership in ongoing
consultation with the Administrative Core, and report progress to institutional leaders and the NCI on a continual
basis. The PEC team will work closely with the Internal Advisory Committee (IAC) and the Program Steering
Committee (PSC) and is composed of two teams: The Evaluation Action Team (EvAT) and the Mentoring and
Project Team. The decisions made by the PEC will be guided by data systematically collected and organized by
the EvAT while the PEC’s Mentoring and Project Team will monitor the provision of support and mentorship of
ChicagoCHEC’s early career faculty, in addition to working closely with the Administrative Core to seed
collaborative, tri-institutional cancer research projects and developmental pilots over the next five-year grant
period. The overall specific aims of the PEC are to: (1) Conduct ongoing tracking and evaluation of all Partnership
activities to inform planning, improve processes, maximize resources, and communicate impact to stakeholders
over the duration of the ChicagoCHEC Partnership, with support of the IAC, PSC, and NCI; (2) Create and
sustain an ongoing Incubator and Catalyst Research Grant Program, encouraging tri-institutional partnership
and a focus on cancer health equity; and (3) Bolster a pipeline of faculty focused on cancer research by
coordinating and monitoring career enhancement, mentoring, and professional development activities for early
career faculty.